Shared Instrumentation Grant application for EchoMRI whole body composition analyzer

Abstract:
This proposal aims to secure funding for acquiring a new generation EchoMRI whole body
composition analyzer to address the urgent need for reliable and advanced research capabilities
that are critical to ensure uninterrupted progress and advance of federally funded projects at
OHSU. The new EchoMRI analyzer is capable of accurate measurements of whole-body
composition in small live animals, which is crucial for investigating metabolic disorders, monitoring
chronic disease progression and understanding disease mechanisms over time, especially in
young animals and during early development. The instrument currently available for OHSU
researchers is 16 years old, obsolete in both hardware and software, plagued by frequent and
unpredictable malfunctions, dwindling manufacturer support, and incompatible to upgrading. Its
increasingly frequent breakdowns have caused significant disruptions, delays and data loss in
NIH-funded studies. The requested new analyzer, with the latest versions of hardware and
software and enhanced capabilities,will not only solve the problemof unpredictableunavailability,
but will also offer expanded test modalities, new measurement capabilities, improved
measurement accuracy and enhanced data safety. It will be procured from the same vendor of
the instrument currently used at OHSU, EchoMRI LLC, which can ensure a seamless transition.
The new analyzer will cost $136,650 and will be managed by the OHSU University Shared
Resources (USR) program, providing access to at least nine NIH-funded research groups and
other OHSU affiliated institutions. With an optimized operation and management team in place,
acquisition of the new EchoMRI analyzer will empower researchers, facilitate breakthrough
discoveries, and contribute to solving critical health issues through investigations on metabolic
and endocrinological pathogenesis and pathophysiologic mechanisms of a broad range of chronic
diseases, of which comprehensive body composition analysis is often an indispensable and
critical part. This proposed investment holds great potential for transformative impacts on
research outcomes and the advancement of excellence in biomedical research.

Public health relevance
Project Narrative: We present an urgent request for funding to purchase a new EchoMRI to replace the existing outdated analyzer which is obsolete in both hardware and software and suffers from frequent and unpredictable malfunctions that cause frustrating disruptions, delays and data loss to OHSU investigators engaged in NIH-funded studies.The new device will solve the current study disruption/delay issues and provide a reliable source of important technical services to ensure smooth progress of NIH-funded studies at OHSU to which body composition data are of critical importance. With advanced technology, enhanced capabilities, and improved accuracy, the new analyzer will revolutionize our research capabilities by offering expanded measurement capabilities, broader test modalities, and increased accuracy. This significant upgrade will unlock new dimensions and research areas that were previously unattainable due to limitations imposed by the outdated analyzer, enabling us to explore new frontier s and make groundbreaking discoveries.